Modeling Drug Induced Liver Injury with Patient-Derived Liver Organoids and Microfluidic Chips

ABSTRACT
Drug-induced liver injury (DILI) is an infrequent but important cause of both acute and chronic liver disease.
The symptoms of DILI can be vague and non-specific, and may not appear until weeks or months after drug
administration. While most cases of DILI are mild and resolve by stopping the offending medication, in some
cases it can lead to liver failure requiring transplantation or death. Additionally, there are no drugs or therapies
that can reverse the liver damage caused by DILI. An estimated 22% of clinical trial failures and 32% of market
withdrawals of novel molecular entities are due to unanticipated hepatotoxicity. The combination of iPSC-
derived human liver organoids (HLOs) from DILI patients with organ-on-chip technology has the potential to
revolutionize DILI risk prediction and may ultimately lead to the development of safer and more effective
medications. We have established a biobank from 15 well-characterized U-M patients enrolled in DILIN along
with methods to engineer liver tissue that can recapitulate their specific disease phenotype to enable
mechanistic inquiry and establish improved animal-free methods for predicting DILI. We propose to fully
develop a next-generation DILI risk prediction platform to improve predictive accuracy and improve our
understanding of the etiopathogenesis and biomarkers of DILI due to specific drugs or HDS products. We
hypothesize that HLOs from diverse DILI patients will provide a novel and scalable platform for risk prediction
and mechanistic inquiry. We will test this hypothesis with three Specific Aims: (1) expand DILI patient biobank
through more patient enrollment to enhance the ethnic and gender diversity and the number of culprit drugs to
characterize more mechanisms of DILI, (2) increase the model complexity by incorporating additional liver cell
types including same-patient immune cells, cholangiocytes, and an endothelial barrier that will be more
physiologically active to enable high accuracy in retrospective prediction of the culprit drug, (3) perform state-
of-the-art single-cell mechanistic studies involving selected drugs including amoxicillin-clavulanate and link
genotype and transcriptional profiles to cellular phenotypes following drug exposure. The top identified targets
will be validated by CRISPR genome editing, functional assessment, and differential hepatotoxicity for DILI
drugs.

Public health relevance
PROJECT NARRATIVE Drug-induced liver injury (DILI) is a serious adverse drug reaction that can occur with the use of many prescription and non-prescription medications and lead to mild-to-severe liver damage. DILI is a leading cause of acute liver failure and the most common reason for drug recalls. This project seeks to develop a next- generation, animal-free human DILI risk prediction platform through human liver tissue engineering and the development of a microfluidic organ-on-a-chip. Results from this study could improve DILI risk prediction and may ultimately lead to the development of safer and more effective medications and identify potential strategies to treat DILI.